Northern New England Clinical and Translational Research Network - N3C Initiative

ABSTRACT
The National Covid Cohort Collaborative (N3C), sponsored by the National Center for Advancing Translational
Sciences (NCATS) and the National Center for Data to Health (Cd2H) have created a centralized national
database on a cloud-based analytic platform for scientists to use to study COVID-19, identify potential
treatments, and report on outcomes and health disparities. It is a partnership among more than 80 institutions
that is funded by the National Institutes of Health. Collaborators have contributed data so far on nearly 8 million
COVID-19 positive patients, as well as several million control patients. The collaborators use the clinical data
on these patients to answer critical research questions to address the pandemic and accelerate development
of effective treatments. The Northern New England Clinical and Translational Research Network has actively
participated in N3C for over 3 years and is submitting this administrative supplement to allow for our continued
participation for another year. This application details our past accomplishments and describes our planned
work for the coming year.

Public health relevance
NARRATIVE COVID-19 has emerged as a major critical health threat to our population. The N3C data registry is an important resource for researchers who are studying COVID-19 effects and treatments. This registry will ultimately contribute to better management and treatment of COVID-19.